Health Effects of Metals in Native American Communities: A Longitudinal Multi-omics Study

Summary of Project 3
Native American populations have high rates of cardiometabolic disease, including cardiovascular disease
(CVD) and diabetes. In the Strong Heart Study (SHS), the most important study of CVD and its risk factors in
Native American communities, we showed that long-term arsenic (As) exposure can explain part of the excess
burden of cardiometabolic disease. Uranium (U) exposure is associated with CVD in occupational cohorts, but
data from general populations are limited. Importantly, As and U are common contaminants in Superfund sites
and tribal lands, so exposure to these contaminants could be partially responsible for increased rates of
cardiometabolic disease in Native American populations. Advancing effective interventions for metal-related
cardiometabolic diseases requires robust data on the lasting effects of past exposures, the joint effects of As
and U, and the relevant mechanisms, including downstream molecular effects. To address these needs, we will
establish the Strong Heart As/U Lifelong (SHAUL) study (n=1,300) by linking data from participants at SHS visit
1 (1989–91) with their offspring recruited during the SHS family expansion in 2001–03 (visit 4). We will leverage
30 years of data and a new visit planned for 2022–23 to address the following aims. (1) Determine the
cardiometabolic effects (diabetes and CVD) of childhood and adult As and U exposures overall and by
sex, region, and nutritional status. Urinary metal biomarkers are available at visits 1 (reflecting childhood
exposure) and 4 (reflecting adult exposure), and will be measured at visits 5 (2006–09) and 7 (2022–23) to
reconstruct lifelong exposures. Water metal data, including spatial patterns, temporal trends, and stable isotope
data tracing potential sources, will be available from Projects 1 and 2. (2) Determine the longitudinal
epigenetic and metabolomic effects of childhood and adult As and U exposures overall and by sex, region,
and nutritional status. We will measure genome-wide DNA methylation (DNAm) at visits 4 and 5, leverage extant
targeted and untargeted metabolomics from the same visits, and use a joint DNAm/metabolomic multi-omics
strategy. (3) Develop a predictive multi-omics fingerprint that quantifies latent and concurrent
cardiometabolic risk due to As and U exposures. We will use machine learning approaches to characterize
DNAm and metabolomic profiles that identify individuals at risk of diabetes or CVD due to past or current metal
exposures. We will also conduct a cross-species multi-omics comparison with Project 4’s mouse data.
Cardiovascular disease, diabetes, and metal exposures are major concerns for our partnering communities in
the Northern Plains. By investigating the latent and concurrent effects of As and U exposures, the SHAUL study
can reveal epigenetic and metabolomic mechanisms for metal-induced health effects, identify susceptible
populations, and inform risk assessment. The findings will have direct implications for the prevention and control
of water contaminants and cardiometabolic diseases in affected communities, including in the Northern Plains,
near Superfund sites, and near other contaminated areas in the US and globally.

Public health relevance
Narrative of Project 3 Arsenic and uranium are major contaminants at Superfund sites, and exposure to these contaminants can partly explain the excess burden of cardiometabolic disease affecting Native American communities in the US. Project 3 will determine the effect of past and current metal exposures in cardiometabolic disease and their longitudinal epigenetic and metabolomic signatures. This study can then reveal molecular mechanisms for metal-induced health effects, identify susceptible populations, and inform risk assessment with direct benefits for the prevention and control of metal exposure and cardiometabolic disease affecting tribal communities in the US Northern Plains as well as other at-risk populations globally.